How does mutant ATXN1 expression in microglia impact Spinocerebellar Ataxia Type 1 pathogenesis?

Project Summary
How does mutant ATXN1 expression in microglia impact Spinocerebellar Ataxia Type 1 pathogenesis?
Spinocerebellar ataxia type 1 (SCA1) is a fatal autosomal dominant neurodegenerative disease without a cure
or effective therapies to delay disease onset and progression. SCA1 is caused by a CAG repeat expansion that
encodes for a polyglutamine stretch in the ATAXIN-1(ATXN1) protein and is characterized by deficits in motor
coordination, dysarthria, and premature death. Prior work has uncovered increased numbers of microglia,
microglia contribution to SCA1 motor phenotypes, and differentially expressed genes in SCA1 microglia.
However, there is still a critical need to understand whether these phenotypes are due to mutant ATXN1
(mATXN1) expression in microglia or surrounding cells. The goal of my proposal is to determine the role
microglial mATXN1 expression plays in motor behavior, microglia molecular phenotypes, and the impact on
surrounding cells. I aim to achieve this by removing mATXN1 from microglia by crossing Lyve1CRE mice with f-
ATXN1146Q/2Q mice. The f-ATXN1146Q/2Q mouse model contains LoxN sites around mATXN1 allowing for
conditional deletion of mATXN1 with Cre recombinase expression. The Lyve1CRE model highly expresses Cre
recombinase in microglia and macrophages. Crossing these two mice will generate f-ATXN1146Q/2Q;Lyve1CRE
mice which will have mATXN1 deleted from microglia and macrophages. I aim to assess the impact of removing
mATXN1 expression in microglia on motor deficits, microglia disease phenotypes, and cerebellar pathogenesis.
Motor function will be assessed through battery of motor assay. Microglia disease phenotypes and cerebellar
pathogenesis will be assessed with a combination of single nuclei and bulk RNA sequencing and
immunohistochemistry. I hypothesize that removal of mATXN1 will ameliorate motor deficits, correct the number
of differentially expressed genes in microglia and other cerebellar cells, and ameliorate microglial reactivity and
cerebellar pathology seen through immunohistochemistry. This research will aid in further elucidating the role
microglia plays in SCA1, a relatively understudied aspect of SCA1. Finally, the training I will receive during this
work is paramount to my goal to become faculty at research university.

Public health relevance
Project Narrative Spinocerebellar ataxia type 1 (SCA1) is an autosomal dominant neurodegenerative disease with no cure. Previous work has elucidated microglia contribution to SCA1 motor phenotypes and microglia molecular phenotypes in SCA1 mice. The goal of this proposal is to investigate how mutant ATXN1 expression in microglia impacts motor function, microglia molecular phenotype, and cerebellar cell pathology, which is vital for understanding the underlying disease mechanisms of SCA1.